Defining the molecular inventory of staphylococcal tissue abscesses and its effects on the host-pathogen interface

6XPPDU\ 0XOWLGUXJUHVLVWDQW EDFWHULDO LQIHFWLRQV SDUWLFXODUO\ WKRVH FDXVHG E\ 6WDSK\ORFRFFXV DXUHXV DUH UHFRJQL]HG DV RQH RI WKH JUHDWHVW WKUHDWV RI WKH VW FHQWXU\ %ORRGVWUHDP LQIHFWLRQV DUH WKH PRVW VHYHUH VWDSK\ORFRFFDO GLVHDVH PDQLIHVWDWLRQ DQG DUH RIWHQ IDWDO GHVSLWH RXU EHVW DQG PRVW FXUUHQW WKHUDSLHV 2UJDQ DEVFHVVHV DUH SULPDU\ FRQWULEXWRUV WR 6 DXUHXV V\VWHPLF LQIHFWLRQV DQG VHUYH DV LQLWLDO UHVHUYRLUV IRU WKH LQYDGLQJ SDWKRJHQ $EVFHVV IRUPDWLRQ LWVHOI IROORZV GLVWLQFW GHYHORSPHQWDO VWDJHV LV DFWLYHO\ IDFLOLWDWHG E\ KRVW DQG EDFWHULXP DQG XOWLPDWHO\ FUHDWHV DQ DGYDQWDJHRXV QLFKH IRU 6 DXUHXV :KLOH SDVW VWXGLHV KDYH JHQHUDWHG DQ RYHUYLHZ RI DEVFHVV DUFKLWHFWXUH ZH ODFN LQIRUPDWLRQ RQ WKH PROHFXODU FRPSRVLWLRQ RI DEVFHVVHV SDUWLFXODUO\ LQ WKH FRQWH[W RI GLIIHUHQW DEVFHVV VWDJHV 7KLV OLPLWHG NQRZOHGJH RI WKH PROHFXODU HYHQWV GXULQJ DEVFHVV IRUPDWLRQ LV HVSHFLDOO\ DODUPLQJ IRU LW KLQGHUV PHDQLQJIXO DWWHPSWV DW WDUJHWHG GHVLJQ RI DQWLVWDSK\ORFRFFDO VWUDWHJLHV 2XU SUHOLPLQDU\ GDWD VKRZ WKDW DEVFHVV IRUPDWLRQ LV FKDUDFWHUL]HG E\ WKH KRVW¶V H[WHQVLYH UHORFDWLRQ RI WUDQVLWLRQ PHWDOV LQ SUR[LPLW\ WR WKH DEVFHVV LQ D SURFHVV NQRZQ DV QXWULWLRQDO LPPXQLW\ &RQVHTXHQWO\ LQ YLYR LPDJLQJ UHYHDOV WKDW EDFWHULD ZLWKLQ WKH DEVFHVV DUH VWDUYHG IRU ]LQF DQG LURQ 6LQFH DYDLODEOH PHWDO OHYHOV FDQ VHUYH DV ELRPDUNHUV IRU LQYDGLQJ SDWKRJHQV ZH K\SRWKHVL]H WKDW IOXFWXDWLQJ HOHPHQWDO GLVWULEXWLRQV RUFKHVWUDWH EDFWHULDO DFWLYLWLHV DVVRFLDWHG ZLWK DEVFHVV IRUPDWLRQ $ORQJ WKHVH OLQHV ZH VKRZHG WKDW ]LQF VWDUYDWLRQ SULPHV 6 DXUHXV IRU VXEVHTXHQW FRQWDFW ZLWK GLIIHUHQW LPPXQH FHOO SRSXODWLRQV %H\RQG WKHVH ILQGLQJV KRZHYHU WKH FKURQRORJ\ DQG IDFWRUV LQYROYHG LQ PHWDO UHORFDWLRQ GHWHFWLRQ RI WKHVH VWLPXOL E\ 6 DXUHXV DQG FRUUHVSRQGLQJ EDFWHULDO UHVSRQVHV DUH HQWLUHO\ XQH[SORUHG :H WKXV SODQ WR DGGUHVV WKHVH TXHVWLRQV LQ WKLV SURSRVDO 2QH FXUUHQW EDUULHU WR WKH GHVLJQ RI PHDQLQJIXO LQYHVWLJDWLRQV LQWR WKH GHYHORSPHQW RI VWDSK\ORFRFFDO WLVVXH DEVFHVVHV LV D VLJQLILFDQW GHJUHH RI DEVFHVV KHWHURJHQHLW\ OLNHO\ D UHVXOW RI GLIIHUHQW GHYHORSPHQWDO VWDJHV RI LQGLYLGXDO OHVLRQV LQ WKH VDPH RUJDQ 7R DFFRXQW IRU WKH QRQV\QFKURQRXV QDWXUH RI WLVVXH DEVFHVVHV ZH KDYH LGHQWLILHG D JURXS RI SRWHQWLDO SURWHLQDFHRXV PDUNHUV IRU GLIIHUHQW DEVFHVV VWDJHV 7KHVH SURWHLQV ZLOO VHUYH DV PROHFXODU FORFNV VR ZH FDQ IROORZ WKH SURJUHVVLRQ RI LQGLYLGXDO DEVFHVVHV WKURXJK WKH GHYHORSPHQWDO SURFHVV %DVHG RQ WKHVH PDUNHUV ZH ZLOO FUHDWH LQ YLYR UHSRUWHUV DQG FKDUDFWHUL]H WKH PROHFXODU LQYHQWRU\ RI GHYHORSLQJ DEVFHVVHV IRFXVLQJ RQ FKDQJHV LQ HOHPHQWDO DQG SURWHLQDFHRXV FRPSRVLWLRQV +HUH ZH ZLOO FRUUHODWH YDULRXV LQ YLYR LPDJLQJ PRGDOLWLHV LQFOXGLQJ 'ELROXPLQLVFHQW LPDJLQJ 05, DQG LPDJLQJ PDVV VSHFWURPHWU\ ZLWK DGYDQFHG SURWHRPLFV YLD PLFUR /LTXLG ([WUDFWLRQ 6XUIDFH $QDO\VLV 2QFH ZH KDYH HVWDEOLVKHG KRZ WKH DEVFHVV PLFURHQYLURQPHQW FKDQJHV GXULQJ GLIIHUHQW SKDVHV RI DEVFHVV IRUPDWLRQ ZH ZLOO SHUIRUP WUDQVFULSWRPH DQDO\VLV RI EDFWHULDO VXESRSXODWLRQV WR DVVHVV KRZ HQYLURQPHQWDO VWLPXOL DIIHFW VWDSK\ORFRFFDO SDWKRSK\VLRORJ\ DQG LQ WXUQ DEVFHVV GHYHORSPHQW &RPELQHG WKH SURSRVHG H[SHULPHQWV ZLOO H[DPLQH WKH HYHQWV DW WKH KRVWSDWKRJHQ LQWHUIDFH DQG SDYH WKH ZD\ IRU QRYHO DQG WDUJHWHG WUHDWPHQW VWUDWHJLHV WR FRPEDW VWDSK\ORFRFFDO LQIHFWLRQV

Public health relevance
Narrative: Tissue abscesses formed by Staphylococcus aureus are important contributors to progression and persistence of infection, largely due to the physical protection they afford to bacteria from circulating immune cells. While general features of the abscess architecture are known, we lack a detailed understanding of the molecular processes that shape abscess formation, a shortcoming that complicates the development of novel anti-staphylococcal strategies. In this proposal, we outline experiments that are designed to overcome these limitations by i) identifying molecular markers of abscess formation, ii) characterizing the elemental and proteinaceous abscess composition throughout different developmental stages of the abscess, and iii) evaluating how S. aureus senses and responds to fluctuations in the abscess microenvironment.